RADIATION THERAPY WITH CONCOMITANT CONTINUOUS INFUSION TAXOL

This is a Phase I study to assess the toxicity of low dose, continuous infusion taxol in combination with standard head and neck radiation therapy in patient with locally advanced, previously unirradiated head and neck squamous cell carcinoma. To determine the maximum tolerated dose of Taxol when given in this manner. To determine the plasma, and if specimen available, tissue Taxol levels achieved. To determine the effect of Taxol delivered in this manner on the tumor cell cycle distribution.